Developing a Decision Tool for Chemotherapy in Older Women with Early Stage Breast Cancer

PROJECT SUMMARY/ABSTRACT
The chemotherapy decision-making process in older women with early-stage breast cancer is complex.
Although older women derive a similar degree of benefit from chemotherapy as compared to their younger
counter-parts, there are other issues such as medical comorbidities and unique adverse effects that may
influence the recommendations of physicians and preferences of patients, subsequently impacting treatment
outcomes. Currently, there are no decision aids available to guide patients in considering tradeoffs between
quality of life and prognosis conferred by their disease and treatment. The literature supports that older
patients desire more active roles in decision-making, and a critical need exists for tools to facilitate patient-
centered communication and shared decision-making. Evidence supports that decision aids enhance shared-
decision making processes. In the proposed project, I will develop a decision aid to meet the information and
clinical needs of older adult women making breast-cancer treatment decisions, and support their physician in
navigating this conversation. The tool will include two components: (1) a physician-facing component that will
incorporate validated breast-cancer risk outcomes, and (2) a patient-facing component that will include an
include education (overview of the disease, goals of therapy), description of benefits/risks of treatment,
feedback on tailored outcome probabilities, and values clarification. My overall hypothesis is that a decision
support tool will provide patients and physicians with tailored information regarding the risks and benefits of
chemotherapy and values clarification to support high quality, shared decisions. An advisory panel composed
of patients, oncologists, geriatricians, nurses and patient advocates will provide regular feedback throughout
the development process and engage in an iterative process of development. We will subsequently evaluate
the tool for acceptability and feasibility through a field test of 20 patients. After incorporating feedback from the
field test to create a finalized version of the tool, we will carry out a cluster-randomized pilot study that will
include randomization to a usual-care arm with the objective of evaluating the efficacy of the decision support
tool by measuring patient-reported outcomes of decisional conflict, knowledge, and a measure of the decision-
process/approach. Ultimately, the results of this project will inform a larger randomized control trial to assess
whether the decision tool improves patient knowledge, decision quality/processes, and quality of life.
Furthermore, through my work on this project and the proposed training activities, I will strengthen by skill-set
in decision science, health communication, qualitative/mixed-methods methodology and clinical trial design
which allow me to transition to my long-term goal of becoming an established independent investigator.

Public health relevance
PROJECT NARRATIVE The decision process regarding treatment with chemotherapy in older women with early-stage breast cancer can be difficult. Patients and physicians as must not only consider the benefits and side-effects of treatments, but also the other medical conditions that a patient may be dealing with and a patient's own personal values and preferences. The goal of our project is the development of a decision-aid to be used by patients and physicians to help navigate this important decision process.